Diagnosis and Treatment of Adult Attention-Deficit/Hyperactivity Disorder: A Workshop

Monica N. Feit, PhD, MPH
Executive Director
Health and Medicine Division
March 31, 2023
RE: NAS Proposal No. AWP-000052
Marta Sokolowska, PhD
Deputy Center Director for Substance Use and
Behavioral Health
Office of the Center Director
Center for Drug Evaluation and Research
Food and Drug Administration
10001 New Hampshire Avenue
Silver Spring, MD 20903
Dear Dr. Sokolowska:
We are pleased to submit the enclosed proposal, prepared by our Board on Health Sciences Policy, requesting support
of a workshop on Diagnosis and Treatment of Adult Attention-Deficit/ Hyperactivity Disorder, hosted by the Forum
on Drug Discovery, Development, and Translation. This is our response to your request for proposal. The total
estimated cost for this project is $307,714 for the period May 1, 2023 through April 30, 2024, of which the Food and
Drug Administration is requested to provide $307, 714.
The responsible staff officer for this study is Carolyn Shore, PhD, Senior Program Officer. She can be reached at 202-
334-2669. Business negotiations are the responsibility of Robert “Skip” Day, Contract Manager, Office of Contracts
and Grants. He can be reached at 202-334-3873.
We appreciate your consideration of this matter.
Sincerely,
Monica N. Feit, PhD, MPH
500 Fifth Street, NW, Washington, DC 20001
Phone 202.334.2383 | [email] | www.nationalacademies.org/HMD

Public health relevance
Project Narrative This public workshop will provide an opportunity for professionals who typically diagnose attention- deficit/hyperactivity disorder (ADHD) (e.g., physicians, psychologists, social workers, nurse practitioners, and other licensed counselors or therapists), drug developers, researchers, regulators, patients, and other stakeholders to examine the diagnosis and treatment of adults with ADHD; and consider opportunities for drug research and development.